Fostering medication adherence in children with epilepsy using mHealth technology

PROJECT SUMMARY/ABSTRACT
Non-adherence to antiepileptic drugs (AEDs) is a common problem (i.e., 58% of patients have some level of
non-adherence) for young children with newly diagnosed epilepsy, with potentially devastating consequences.
AED non-adherence is associated with a 3-fold increased risk of seizures, poor quality of life, inaccurate
clinical decision-making, and higher health care utilization and costs. One of the primary barriers to adherence
is forgetting, which may be particularly amenable to mHealth (mobile technology in healthcare) interventions.
Despite the critical need to develop and implement interventions to improve adherence, there are few family-
based interventions for young children with epilepsy and their families, with the exception of the PI's pilot and
existing R01 trial. Although highly promising, this intervention requires six in-person sessions, which can be
impossible for families who lack routine access to tertiary specialty care due to time, financial, or transportation
constraints. Thus, unmet medical and psychosocial needs of the underserved pediatric epilepsy population are
perpetuated and compounded by limited access to this state of the art care. Our overall goal is to test a
mHealth adherence intervention that is easily accessible using a stepped up care model based on individual
needs. This stepped up care model will conserve patient, family, and provider time, costs and resources. The
aim of this multi-site R01 is to conduct a two-stage, sequential, multiple assignment, randomized trial (SMART)
to evaluate the effectiveness of mHealth intervention strategies for improving AED adherence in caregivers of
young children with epilepsy. A two-month baseline period will be followed by two stages. In Stage 1 (3-months
long), non-adherent caregivers (< 95%) will be randomized to a mHealth education module and automated
digital reminders (control) or the mHealth education module, automated digital reminders, and individualized
adherence feedback based on real-time adherence monitoring (treatment) to address the primary barrier of
forgetting. At the beginning of Stage 2 (two months long), caregivers randomized to treatment who do not
achieve adherence > 95% (response) by the end of Stage 1 will be re-randomized to either continued
individualized adherence feedback or individualized adherence feedback augmented with two mHealth
problem-solving modules (translated from the PIs existing RCTs) with a therapist. Thus, there are three
intervention strategies embedded in this SMART: #1 control, #2 treatment, and #3 problem-solving augmented
treatment if nonresponsive at three months. The primary outcome is electronically-monitored adherence and
secondary outcomes include seizure severity/frequency, quality of life, and healthcare utilization. If the aims of
the project are achieved, this study would have a large impact on pediatric epilepsy, with the potential to
change clinical practice for treating non-adherence. The SMART design would allow us to identify patients who
are most likely to respond to interventions and step up care with more time- and resource-intensive
interventions (i.e., problem-solving with a therapist via the web), when necessary.

Public health relevance
NARRATIVE: Fifty-eight percent of children with new-onset epilepsy do not take their antiepileptic drugs (AEDs) as prescribed, which is associated with continued seizures, mortality, poor quality of life, and high healthcare costs. Evidence-based adherence interventions are lacking and critically needed, especially for children with epilepsy, who represent an underserved population in pediatrics. The current proposal is a mHealth sequential, multiple assignment, randomized trial (SMART) focused on providing mobile health tools and strategies (education, automated digital reminders, individualized adherence feedback, problem-solving skills) to youth with epilepsy to improve adherence and quality of life and decrease seizures and health care utilization.